Advanced Research Training in the Biology of the Inner Ear and Related Systems

PROJECT ABSTRACT
Inner ear dysfunction and the associated problems with hearing and balance affect about 30 million Americans
and that number is expected to grow as the population ages. Despite the enormous socioeconomic impact,
however, hearing and balance are the most poorly understood of all the senses. One significant reason for this
gap in our knowledge is the technical difficulties unique to inner ear research that are a discouraging barrier to
new investigators. To address this challenge, we have designed an ambitious three-week course, the Biology
of the Inner Ear (BIE) course, to train new investigators in advanced research approaches to the biology of
hearing and balance. In each course, 18 students are taught by a team of leading scientists and clinicians.
The course will be held in the summers of 2021, 2023 and 2025 at the Marine Biological Laboratory (MBL) in
Woods Hole, MA. For the intervening summers of 2022 and 2024, we plan on-site orientation programs for
faculty from under-represented groups or who are hearing impaired, with the goals of increasing the diversity of
faculty role models at the BIE course and attracting a greater diversity of students. The BIE course was first
offered in 2007 and thereafter biennially through 2019. Each course was very well-received by students and
faculty, and their feedback provided successive improvements, culminating in the present curriculum. Using
the focused approach that typifies other highly successful MBL courses, BIE is designed to meet specific
needs of new researchers in auditory and vestibular science. The course will continue to enroll a class
comprising graduate students, postdoctoral researchers, clinician-scientists, and established investigators
entering the field for the first time. These talented students will be provided with instruction and hands-on
laboratory training in cutting-edge, rigorous techniques and specialized methods that are unique to
investigations of the inner ear and auditory, vestibular, and lateral line systems. Through lectures, research
seminars, roundtable discussions, tutorials, and informal interactions as students and instructors work side-by-
side in the laboratory, the BIE course will foster the development of the students as investigators and provide
the opportunity to establish long-lasting mentoring relationships. These interactions will emphasize problems,
concepts, and theories that are driving current research; innovative approaches; and strategies to translate
discoveries into meaningful improvements in human health. BIE is designed to enhance the pipeline of
talented, highly motivated scientists entering the field, providing instruction that will challenge them and help
them undertake independent and original research, and introducing them to networks within the hearing and
balance community that will encourage their career development. This training will advance the pace of
scientific discoveries and promote their translation into treatments that improve the lives of those suffering from
hearing and balance disorders.

Public health relevance
PROJECT NARRATIVE A three-week intensive lecture- and laboratory-based course will be held at an institution renowned for advanced research courses, with the overall goal of attracting new investigators to research on normal and disordered hearing and balance. Course participants at various stages of training (all post-undergraduate) will work shoulder-to-shoulder with many expert course faculty to learn cutting-edge experimental approaches specific to auditory and vestibular biology as well as the potential for conducting research that improves the lives of patients. The course experience will initiate scientific networks for the course participants and, as a corollary benefit, increase interactions among established investigators from different sub-fields of hearing, balance, and related research.